Mechanisms of Resilience to Alzheimer's Disease Neuropathology

PROJECT SUMMARY/ABSTRACT Alzheimer’s disease (AD) is the most common and severe age-associated neurodegenerative dementia for which finding a resolving cure is a pressing national priority. The discovery of resilient individuals who remain cognitively intact despite the presence of AD neuropathology normally associated with fully symptomatic stages of the disease, suggests that there is a way for the brain to evade dementia even in the face of AD. It follows that understanding the mechanism(s) involved in such extraordinary resistance would reveal targets for the development of a novel, effective therapeutic concept based on inducing cognitive resilience in anyone challenged with AD neuropathology. With this goal in mind, we have discovered that brain synapses in these unaffected individuals are resistant to the disrupting binding of toxic oligomers of both amyloid beta (Aβ) and tau (an event linked to onset of dementia in AD) and that this resistance is associated with the presence of higher numbers of neural stem cells (NSC) in the hippocampus as compared to either AD patients and control subjects. While these observations suggest a link between high NSC numbers and synaptic resistance to damaging amyloid oligomers, the involved mechanism (an obvious treatment target) remains unknown. Based on exciting new, compelling preliminary data involving exosomes specifically released from NSC as mediators of this phenomenon, in this project we will test the hypothesis that NSC-derived exosomes (via delivering specific microRNA cargoes to target neurons) render neuronal synapses resistant to the disrupting binding of Aβ and tau oligomers and thus protect from associated memory deficits. Employing both ex vivo and in vivo models of Aβ and tau oligomer-induced synaptic dysfunction and cognitive impairment, in Aim 1 we will test the hypothesis that NSC-derived exosomes reduce synaptic susceptibility to amyloid oligomers binding and its functional consequences. In Aim 2 we will characterize microRNAs uniquely present in NSC-exosomes responsible for these effects. In Aim 3 we will document the translational value of this novel mechanism employing human NSC and neurons derived from iPSCs. At the completion of the proposed studies we will have documented a previously unappreciated phenomenon of synaptic resistance to Aβ and tau oligomers mediated by NSC-exosomes and discovered specific miRNAs that can promote it. Given the translational value of miRNAs for drug development, this discovery will have a substantial impact in the field by illustrating targets for the development of an innovative treatment concept for AD centered on promoting synaptic resistance to toxic oligomers, a strategy expected to be effective in humans as suggested by the existence of NDAN subjects. A uniquely qualified investigative team has been assembled to successfully accomplish this project, bringing together expertise in AD molecular neurobiology (Taglialatela), NSC biology (Micci), biochemistry of amyloid proteins (Kayed), miRNA sequencing and analysis (Widen), electrophysiology and animal behavior (Krishnan) and neurobiology of NSC-derived exosomes and their miRNA cargoes (Cai, sub-contract PI).

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because of its focus on identifying previously unappreciated molecular/cellular mechanisms linking preserved numbers of neural stem cells in the hippocampus to cognitive resilience in Alzheimer’s disease (AD). This is ultimately expected to drive the development of a novel, effective preventive/curative therapy for AD, thus improving these patients’ health while driving down the societal cost for their care, which is expected to increase to unbearable proportions by the year 2050. Thus, the proposed research is relevant to the part of NIH’s mission concerned with fostering creative discoveries and their application to advance the Nation’s capacity to protect and improve health.